EFFECTS OF EXERCISE ON CORONARY BLOOD FLOW: INFLUENCE OF THE ADRENERGIC SYSTEM

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The aim of this study is to determine the effects of handgrip exercise on CBF before and after a and b-adrenergic blockade to determine the relative contribution of a and b-adrenergic activation on the coronary vasomotor responses.